Biology of Influenza Virus Transmission

PROJECT SUMMARY
The long-term goal of this project is to obtain a better understanding of the molecular determinants for
influenza A virus (IAV) infectivity and susceptibility in order to devise better strategies for prevention of IAV
transmission. Our approach emanates from the existing limitations of our seasonal inactivated influenza virus
(IIV) vaccine in which low vaccination coverage and vaccine effectiveness restrict the desired protection from
viral acquisition, shedding, and continued transmission. This points to a critical need to devise new strategies to
interrupt host-to-host transmission.
Our understanding of the host factors contributing to viral contagion is very limited due to the complexities
of studying natural transmission in humans and a lack of tractable animal models. Furthermore, most
transmission studies in experimental models do not account for host characteristics that could affect IAV
transmissibility and susceptibility. Hence, we recently developed an infant mouse model of intra-litter IAV spread
that enables elaborate studies of the biology of influenza virus transmission. From this model, we established
that high titers of virus shed by the infected donor correlates with the efficiency of transmission, which is
dependent on various host factors (such as age and immunity) and viral factors (such as hemagglutinin and
neuraminidase). Furthermore, manipulations of the upper respiratory tract (URT) environment (via Streptococcus
pneumoniae colonization) revealed that bacterial sialidase expression limited the IAV acquisition by recipients.
Together, our preliminary data suggested that the infectivity of IAV relies on the amount of shed virus from the
donor to overcome a transmission bottleneck, whereas the susceptibility to IAV relies on the availability of sialic
acid in the URT of recipients which may vary, based on the composition of the URT flora. The molecular
determinants of virus shedding and sialic acid availability in the URT have not been the focus of previous
investigation, vaccine, or therapeutic design. Therefore, in Aim #1, we will evaluate the IAV transmission
bottleneck by defining viral and host factors influencing the infectivity (via shedding) of the donor, whereas in
Aim #2, we will evaluate the role of sialic acid in the susceptibility to IAV infection through transmission. At the
conclusion of the project, we will understand the roles of the host and virus in the infectivity and susceptibility to
IAV. We hope to determine whether virus shedding and/or sialic acid availability can be targeted in future studies,
as a novel approach to inhibit IAV contagion.

Public health relevance
PROJECT NARRATIVE Influenza virus infections and transmission continue to pose a significant disease and financial burden in society on an annual basis, despite the existence of a preventative vaccine and antiviral therapies. This project aims to understand how viral and host factors contribute to intra-species transmission of influenza viruses using a novel tractable animal model. This work will open unique concepts in vaccine and therapeutic design directed at preventing influenza virus transmission by targeting virus shedding in the donor and/or sialic acid availability in the recipient.